Progression of Arterial Aging: the Local MCP-1/MMP-2/TGF-beta 1 Signaling Loop

The coexistence of vascular smooth muscle cell (VSMC) invasion, proliferation, and excessive collagen deposition within a diffusely thickened intima is a hallmark of central arterial wall inflammatory remodeling with advancing age. However, the molecular and cellular mechanisms remain poorly understood. Immunostaining, immunoblotting, and RT-PCR analyses of rat aortic walls demonstrate that proinflammatory molecules, including monocyte chemoattractant protein-1 (MCP-1), transforming growth factor beta 1 (TGF-β1), and matrix metalloproteinase type II (MMP-2), increase in mRNA and protein levels within the aging aortic wall. Treating VSMCs isolated from young (8-month-old) Fischer 344 crossbreed Brown Norway (FXBN) rats with MCP-1 via the CC-chemokine receptor 2 (CCR-2) promotes increases in TGF-β1 activity and MMP-2 activation to levels observed in untreated VSMCs from old (30-month-old) FXBN rats. Similarly, treating young VSMCs with TGF-β1 increases MCP-1 and MMP-2 activation to levels seen in old VSMCs. This autocatalytic signaling loop enhances collagen production and VSMC invasiveness, which can be suppressed by silencing the MCP-1 gene, using a CCR2 antagonist, or inhibiting MMP-2. Activated MCP-1, MMP-2, or TGF-β1 can trigger a feed-forward signaling mechanism driving age-associated arterial proinflammatory remodeling.
The active MMP-associated activation of TGF-β1 plays a crucial role in the stiffening of aging VSMCs and arterial walls. Primary VSMCs isolated from thoracic aortae of young versus aged FXBN rats show that aged VSMCs exhibit increased stiffness and frictional moduli due to an internal actin cytoskeleton network. TGF-β1 reinforces the mechanical phenotype of arterial aging in VSMCs through clustering mechanosensitive receptors α5β1 and αvβ3 integrins. Similar observations are made in perivascular adventitial fibroblasts with age. Broad-based inhibition of TGF-β1 expression or signaling in VSMCs and adventitial fibroblasts may mitigate age-associated arterial wall stiffening, hypertension, atherosclerosis, and vascular-related dementia.
Inhibiting MMP-2 activation associated with TGF-β1 activation decelerates age-associated arterial proinflammation and increases in arterial systolic blood pressure. Eight months of chronic administration of the broad-spectrum MMP inhibitor, PD166793, to 16-month-old rats blunted the expected age-associated increases in arterial pressure. This treatment inhibited age-associated increases in aortic gelatinase and interstitial collagenase activity, preserved elastic fiber network integrity, reduced collagen deposition, and decreased MCP-1 and TGF-β1 activation. It also increased vasorin, an inhibitor of TGF-β1 signaling, decreased the activity of the profibrogenic signaling molecule SMAD 2/3 phosphorylation, inhibited proendothelin 1 activation, and downregulated V-Ets Avian Erythroblastosis Virus E26 Oncogene Homolog 1 (Ets-1) expression. MMP inhibition significantly reduced the degradation of tropoelastin in VSMCs, diminishing age-associated arterial proinflammation and systolic blood pressure increases.
A signaling interrelationship exists between angiotensin II (Ang II), TGF-β1, MMP-2, and vasorin within aging VSMCs. In vivo studies in old versus young FXBN rats show that aortic transcription and translation levels of vasorin markedly decrease with aging. In vitro studies of early passage VSMCs from old versus young rat aortae indicate substantial reductions in vasorin protein abundance. Ang II-associated reduction of vasorin in young VSMCs and age-associated changes in vasorin levels are reversed by Losartan, an Ang II receptor (AT1) antagonist, in both in vitro and in vivo conditions. Age-associated arterial vasorin is closely linked to enhanced MMP activation, with aging significantly decreasing cardiac vasorin expression. Maintaining the balance of full-length vasorin/TGF-β1 signaling is a novel approach to hinder age-associated MMP-2 activation and adverse cardiovascular extracellular matrix remodeling.
Collagen type I-activated Discoidin Domain Receptor 2 (DDR2) mediates Ang II-stimulated transcriptional upregulation of fibronectin by Yes-activated Protein in cardiac fibroblasts. siRNA-mediated fibronectin knockdown attenuates Ang II-stimulated expression of collagen type I and anti-apoptotic cIAP2, enhancing susceptibility to apoptosis. An obligate role for fibronectin in Ang II-stimulated expression of AT1R links extracellular matrix remodeling with Ang II signaling in cardiac fibroblasts. DDR2-null mouse myocardium shows reduced basal levels of AT1R and myocardial Integrin-β1 levels, indicating that targeting DDR2 could prevent and treat fibrosis-associated cardiac dysfunction in aging and heart injury.
Arterial aging is linked to increased Angiotensin II (Ang II) signaling via the Ang II type 1 receptor (AT1R). The AT1R-associated protein (ATRAP/Agtrap) binds to AT1R, promoting its internalization and inhibiting Ang II signaling. The role of microRNA-34a (miR-34a), which increases with age, in Ang II signaling is not well understood. The current study investigates whether miR-34a interacts with ATRAP/Agtrap to modulate Ang II signaling in arterial vascular smooth muscle cells (VSMC). miR-34a and gene expression were quantified using RT-qPCR, while protein levels were assessed by immunoblotting and immunohistochemistry. The direct binding of miR-34a to target mRNA was evaluated using a 3'UTR-luciferase assay. Results showed an age-associated increase in miR-34a in Rhesus Monkeys' common carotid artery and rat aorta. AGTRAP protein expression was lower in aged rat VSMC and mice aorta. Ang II increased miR-34a levels in aged rat VSMC and human aortic smooth muscle cells (HASMC), while inhibiting AGTRAP and SIRT1 mRNA/protein expression. In miR-34a-overexpressing HASMC, AGTRAP and SIRT1 mRNA/protein levels decreased, effects that were reversed by forced AGTRAP expression. miR-34a was found to directly target AGTRAP, and AGTRAP downmodulation increased miR-34a and decreased SIRT1 in HASMC. Ang II and miR-34a-induced upregulation of pro-inflammatory genes IL-6, COX-2, MCP-1, and MFGE8 in HASMC was abolished by forced AGTRAP expression. Our findings indicate that Ang II upregulates miR-34a, creating a negative feedback loop on AGTRAP that enhances Ang II signaling, and highlights a potential miR-34a/AGTRAP role in vascular aging.